Methamphetamine Effects on Prefrontal Cortical PV+ Interneurons and Resulting Cognitive Deficits

Project Summary
Neuropsychiatric disorders are a very serious medical and societal problem with many different origins,
however, a common and prevalent deficit found in these disorders is hypofrontality. Emerging theories posit
that hypofrontality [alterations in the ratio of excitatory (E) and inhibitory (I) synaptic transmission] underlie
schizophrenia, anxiety, addiction, autism spectrum disorders and depression.
Methamphetamine (METH) addicts frequently develop hypofrontality and deficits in working memory
(WM), attention, and impulsivity. Similarly, in rodents, repeated psychostimulant administration or self-
administration elicits hypofrontality, WM deficits, psychosis-like behaviors, decreased interest in external
stimuli and surroundings, and decreased social functioning, suggesting that psychostimulant administration
in rodents represents a strong, face-valid model for studying the basic brain mechanisms that underlie
hypofrontality and cognitive disabilities in METH addiction.
The overall objective of the proposed studies is to identify the effects of METH-SA on the activity of cortical
parvalbumin positive fast spiking interneurons (PV+FSIs) and the resulting changes in E-I ratio.
The central hypothesis- informed by strong preliminary data and literature- is that METH treatment elicits
cognitive deficits due to an increase in GABAergic synaptic transmission in the PFC via D1R activation of
PV+FSIs. The proposal’s rationale is that the experiments will yield fundamental knowledge pertaining to the
understanding of the cellular and synaptic mechanisms underlying hypofrontality induced by METH and will
provide new insights into the basic mechanisms governing E-I balance in the prefrontal cortex. We will test the
central hypothesis by pursuing the following specific aims: Aim 1 will determine the role of PV+FSIs in METH-
induced cognitive deficits. Aim 2 will determine whether D1R signaling in PFC PV+FSIs is required for METH-
induced enhancements of GABAergic transmission. Aim 3 will determine whether D1R signaling in PFC
PV+FSIs is required for METH SA-induced cognitive deficits and METH reinstatement.
The proposed research is significant because it will fill a fundamental gap in knowledge pertaining to the
mechanisms underlying hypofrontality in METH-addiction and the effects of the psychostimulant in the activity
of cortical PV+FSIs. Furthermore, the knowledge obtained from the proposed experiments will help to develop
effective treatments to ameliorate drug-related cognitive deficits and can provide new insights into the basic
mechanisms underlying hypofrontality in other neuropsychiatric conditions.

Public health relevance
Narrative: The goal of the proposed studies is to better understand the cortical changes in excitatory-inhibitory balance that may underlie the cognitive deficits elicited by METH abuse. Furthermore, since cognitive deficits occur not only in psychostimulant abusers but also in a variety of different neurodevelopmental disorders, the knowledge generated by this proposal may provide new pharmacotherapeutics targets for multiple disorders that produce cognitive dysfunction.